Michigan Center for Urban African American Aging Research - Analysis Core (AnC)

Analysis Core (AnC) Abstract
The overarching goals of the Analysis Core (AnC) are to support innovative research into social and behavioral
processes underlying health inequities, and to train junior investigators on the tools and approaches that will
enhance the rigor of their research to generate meaningful insights regarding the health and well-being of older
African Americans. The objectives of the AnC are twofold. The first objective is to provide MCUAAAR
Scientists, HBCU affiliates, and Center faculty with the methodological and analytical tools necessary to
conduct and complete pilot projects and RCMAR-related research in a manner that is both transparent and
rigorous. This objective involves providing training, consultation, and logistical support in (a) state-of-the-art
approaches to study design, data collection, and data analysis, and (b) NIH best-practices in rigor and
reproducibility, including study pre-registration, coding and documentation, and data sharing. The second
objective is to embed collaborative, interdisciplinary team science into research practice through a thematic,
case-based training framework informed by the biopsychosocial model. Collectively, these objectives seek to
generate novel scientific insights and methodological approaches to reduce inequities in health and promote
well-being of African Americans over the life course. The AnC has expertise and experience supporting a wide
range of projects (i.e., primary data collection, secondary data analysis, mixed-methods designs, advanced
statistical techniques, and machine learning tools) and provides a forum for Scientists to gain meaningful
exposure to methods from a wide range of disciplinary orientations. The AnC objectives leverage long-
standing, mutually-beneficial relationships with the other MCUAAAR Cores, networks of NIA, NIH and
University centers, organizational partners, and initiatives at UM, WSU, and MSU that have a shared
commitment to applied social and behavioral science and to mentoring junior investigators. We fully expect,
based on our prior interactions, that the analytic methods and training tools developed by the AnC will be
shared within the MCUAAAR, with the RCMAR Coordinating Center and NIA and NIH collaborating centers,
organizational partners, HBCU affiliates, and the broader scientific community.